The Helicase and Nucleic Acid-based Machines Conference: Structure, Mechanism, Regulation and Roles in Human Diseases

Project Summary/Abstract
The goal of this application is to obtain funding to support the biennial FASEB conference
Helicases and Nucleic Acid-Based Machines: Structure, mechanism, regulation, and roles in
human diseases, July 16-20, 2023, in Southbridge, MA. This will be the 14th meeting of this
conference. The FASEB mission is to “advance health and well-being by promoting research
and education in biological and biomedical sciences through collaborative advocacy and service
to our member societies and their members”. The 2023 conference will focus on the roles of
DNA and RNA helicases, which define fundamental processes of gene expression, genome
integrity, and viral replication. Two training sessions are planned for our attendees: one “Meet-
the-Experts” session, which will include a range of topics from starting your own lab to work-life
balance and a diversity, equity, and inclusion (DEI) keynote address that will be positioned
during dinner for maximum attendance. The requested funds will support limited travel for
invited speakers and travel awards for students and postdocs, junior faculty, and our invited DEI
speaker. Nine topical sessions are scheduled which range from post-translational gene
regulation to DNA damage and repair, all of which are intimately connected to human diseases.
This is especially true for cancer subsets as DNA damage, inefficient or incomplete repair, and
aberrant gene expression are well known hallmarks.

Public health relevance
Project Narrative The FASEB conference on Helicases and Nucleic Acid-Based Machines: Structure, Mechanism, Regulation, and Roles in Human Diseases brings together the leading researchers investigating enzymatic transactions that occur to DNA or RNA substrates. The topics include many enzymes directly related to disease mutations that correlate with predispositions to cancer, aging, infertility, immunodeficiencies, and developmental abnormalities. Together, the participants and speakers will reveal mechanistic and biological insights into nucleic acid processing that are vital to developing novel strategies for the treatment of these diseases.